Factors influencing screen media use in low-income Mexican American toddlers

Project Summary/Abstract
Low-income Latino children are disproportionately affected by obesity starting in early life. Poor health
behaviors contribute to obesity, even from this early age. Unhealthy screen use behaviors are known
predictors of short sleep duration, poor diet, and obesity in children ≥ 3 years old, with growing, yet limited,
evidence in children <3. Because low-income Latino children are more likely to have unhealthy screen use
behaviors than low-income non-Latino white children, interventions addressing screen use in this population
are critical to efforts to reduce obesity disparities. Evidence, including our own, suggests parental television
(TV) use behaviors and TV-related parenting practices are predictors of TV use in children ≥ 3. Today,
however, >80% of children use screen devices (e.g. TV, tablet) before age 3. Despite this, little is currently
known about the factors contributing to the development of screen use before age 3, or the relationship of such
early screen use with sleep, diet, physical activity, and body mass index (BMI). Because screen use behaviors
track throughout childhood, intervening on screen use before age 3 may have a lasting impact. By advancing
our understanding of how screen use behaviors develop and are related to health outcomes among low-
income Latino children <3, we can begin to develop early life interventions to reduce unhealthy screen use in
this population. This application’s objective is to identify factors related to early childhood screen use behaviors
in low-income Latino children and how those behaviors are, in turn, related to child health outcomes. In this 5-
year study, we will recruit low-income Mexican American mothers and fathers with 15 - <27 month olds.
Using a mixed methods approach, we will first collect qualitative data from ~40 mothers and fathers to identify
parental behaviors and cultural factors related to child screen use in order to adapt/develop measures for this
age group (Aim 1). We will then collect quantitative data from 385 families to evaluate associations among
parental screen-related behaviors, child screen use, and child sleep duration, diet, physical activity, and BMI
(Aim 2) and evaluate the association of sociocultural factors with parental screen-related behaviors (Aim 3).
Our central hypothesis, based on family systems theory, is that mothers’ and fathers’ screen use and screen-
related parenting practices shape child screen use, which is associated with shorter sleep duration, poor diet,
less physical activity, and greater BMI. Based on the ecological model, we also hypothesize parental screen-
related behaviors occur within a sociocultural context. Our long-term goal is to design a clinic-based
intervention promoting healthy screen use in low-income Mexican American children < 3 years old. This study
will produce novel data on the relationship of parental screen-related behaviors with child screen use and
related health outcomes, and the context within which these behaviors occur. In this digital era of highly
accessible screens introduced at very early ages, it is imperative that we identify factors associated with early
screen use so that we can effectively promote healthy screen use behaviors when they are first developing.

Public health relevance
Project Narrative Unhealthy screen use, which starts very early in childhood, is associated with childhood obesity, a condition that disproportionately affects low-income Latino children. By advancing our understanding of how screen use (e,g, TV, tablet) behaviors develop in early life, the sociocultural context of use, and the relationship of early screen use with child sleep, diet, physical activity, and body mass index among low-income Mexican American children <3 years old, this study will provide the basis for developing culturally-tailored, family-based interventions promoting healthy screen use in early childhood in a large population at high risk for early childhood obesity. Moreover, the findings will inform national child screen use guidelines and clinical care.